Role of Valosin-Containing Protein (VCP/p97) in Cadmium-Disturbed Proteostasis

DESCRIPTION (provided by applicant): Cadmium (Cd2+) poisoning is a serious health threat due to increased level of environmental pollution and lack of effective therapy. An extremely long biological half-life of Cd2+ in the human body leads to a persistent and cumulative effect. Chronic exposure to Cd2+ causes disorders of the nervous, renal, skeletal, vascular, and respiratory systems. A common pathophysiological feature of these seemingly unrelated diseases is imbalanced protein homeostasis (proteostasis). Evidence reported from our laboratory, as well as others, suggests that Cd2+ prevents the degradation of ubiquitinated proteins in human cells, and the cytotoxicity of Cd2+ can be alleviated by increasing the degrading capacity of the ubiquitin proteasome pathway in cells. However, Cd2+ does not affect proteasome activity directly. Why ubiquitinated proteins cannot be degraded in Cd2+ treated cells remains as a critical open question. Valosin-containing protein (VCP/p97), a molecular chaperone, lies at the heart of proteostasis to unfold ubiquitinated proteins for proteasomal degradation. A structural Zinc (Zn2+) located in the center pore of VCP is essential for ubiquitinated protein degradation. Since Cd2+ can substitute for Zn2+ in some proteins to change protein structure and protein function, we hypothesize that the replacement of the structural Zn2+ by Cd2+ results in loss of VCP function, and this leads to a reduction in ubiquitinated protein degradation. We propose to examine the ATPase activity and hexamer structure, two essential features of VCP in mediating protein degradation, as well as the biological actions of Cd2+-containing VCP, in an effort to understand the loss of functional activity. Our long-term goal is to define the biochemical basis for the disturbance of proteostasis underlying the protein misfolding induced by heavy metal ions. We believe these studies will contribute to a better understanding of the pathogenesis of Cd2+-associated diseases and advance the development of preventive and/or therapeutic strategies for these disorders. 1

Public health relevance
PUBLIC HEALTH RELEVANCE: Cadmium is an environmental pollutant which causes a number of chronic diseases in the nervous, renal, skeletal, vascular, and respiratory systems. In particular, chronic exposure to cadmium from industrial exposure or cigarette smoke is the primary cause of chronic obstructive pulmonary disease (COPD), which is the fourth leading cause of deaths in the United States and is projected to increase in prevalence, thus posing a daunting challenge to public health. It has a decade-long biological half-life, and no treatment is currently available to remove cadmium from the human body. This proposal aims to elucidate underlying mechanisms responsible for cadmium related diseases and to identify molecular targets for the development of therapies to improve the health of these patients. __SpecificAimsTextDelimiter__ Specific Aims: Cadmium (Cd2+) is one of the most toxic heavy metal ions, present in the environment as a serious pollutant. The biological half-life of Cd2+ in the human body is approximately 14 years. Chronic exposure to Cd2+ causes systemic injury in the nervous, renal, skeletal, vascular, and respiratory systems. There is no effective treatment for the chronic diseases caused by Cd2+. A common pathophysiological feature of these seemingly unrelated diseases is imbalanced protein homeostasis (proteostasis). Results reported by our laboratory and other groups show that a unique cytotoxicity feature of Cd2+ is to suppress the degradation of ubiquitinated proteins. In agreement with these results, experimental treatments which increase the degrading capacity of the ubiquitin proteasome pathway attenuate the cytotoxicity of Cd2+. However, the molecular mechanism of Cd2+ induced imbalance of proteostasis remains puzzling since Cd2+ does not inhibit proteasome activity directly. The overall goal of this proposal will focus on understanding the molecular basis underlying the Cd2+ induced imbalance in proteostasis pathway. Valosin containing protein (VCP/p97), a member of ATPase associated with various cellular activities (AAA) family, lies at the heart of regulating proteostasis. It mediates the proteasomal degradation of ubiquitinated proteins and retrotranslocates ubiquitinated proteins from endoplasmic reticulum (ER) into cytoplasm for degradation. For optimal functional activity, VCP requires an intact hexameric structure, ATPase activity, and proper conformational change during ATP hydrolysis cycle. Structurally, VCP is composed of an N domain, D1 and D2 ATPase domains, and each possesses important functional activities. A structural Zinc (Zn2+) ion is bound to histidine 317 (H317) in the center pore of the VCP hexamer (Zn2+-VCP), which is indispensible for the degradation of ubiquitinated proteins including ER associated degradation. Based on our previous studies on the biochemical characterization of VCP, and the well established chemical capacity of Cd2+ to bind with high affinity to Zn2+-binding sites in many metalloproteins, we hypothesize that the substitution of Zn2+ by Cd2+ in VCP (Cd2+-VCP) impairs the degradation of ubiquitinated proteins by decreasing its ATPase activity and altering the conformational change of VCP. Two specific aims are proposed to test this hypothesis. Specific Aim 1. To characterize the ATPase activity and hexamer structure of Cd2+-VCP. We will conduct structural and functional studies to examine the effect of Cd2+ on the ATPase activity of VCP. We will also determine the Cd2+ effect on the hexamerization and conformational shift of the molecule during the ATP hydrolysis cycle. This aim will reveal how Cd2+ changes these essential structural and biochemical properties of VCP. Specific Aim 2. To examine the capacity of Cd2+-VCP to mediate proteasomal degradation. We will test whether Cd2+-VCP is able to mediate the degradation of ubiquitinated proteins using an in vitro protein degradation system. In addition, the effect of Cd2+ on ER associated degradation of ER-produced, important lung proteins, such as the cystic fibrosis transmembrane conductance regulator (CFTR) and alpha-1 antitrypsin (AAT), will be examined in pneumocytes. Finally, the effect of Cd2+ on the interaction between VCP and its cofactors for protein degradation will be examined. This aim will directly clarify the effect of Cd2+ on VCP- mediated proteasomal degradation. If successful, the findings will represent a novel molecular mechanism to explain Cd2+ induced proteostasis imbalance, which would have immediate impact on biometal research by introducing new concepts on its toxicological mechanism. Furthermore, the results of this project will provide unique insights into the fundamental cellular and molecular mechanisms underlying protein quality control and pathophysiology of Cd2+-based diseases. Translational development of novel therapies to restore the function of VCP may help in the prevention and/or treatment of these disorders. 1